Active non-viral nuclear delivery of DNA templates independent of mitosis

PROJECT SUMMARY
Progress in genomic medicine is hampered by safety, toxicity, immunogenicity and cargo capacity/size concerns
inherent to the use of lentiviral and retroviral methods. Non-viral methods of gene delivery are highly attractive
to meet the demand for effective, scalable gene therapies and largely address insertional mutagenesis; however,
nuclear delivery after endosomal escape is a large bottleneck that needs to be overcome. Lipid nanoparticles
are clinically approved for delivery of nucleic acids, but payloads are largely limited to the cytosol, with very
modest nuclear entry. To address the nuclear delivery bottleneck, Kano Therapeutics’ proposed solution utilizes
gene repair templates with DNA targeting sequences, designed by our team of experts using our proprietary in
silico platform to enable nuclear entry, achieve efficient integration, and minimize potential immunogenicity. Kano
Therapeutics’ fully custom, circular single strand DNA (cssDNA) is an optimal payload for gene editing, with high
integration efficiency and minimal off-target effects. Our pipeline for fully custom cssDNA production enables
production and proven integration of kb-size templates, which can revolutionize the field of genomic medicine
and lead to permanent cures of monogenetic disorders. Our nucleic acid engineering know-how, together with a
highly scalable and low-cost patented manufacturing process, makes us hopeful that we can drive progress in
the gene editing field for a variety of indications. In this Fast-Track application we aim to thoroughly investigate
active nuclear delivery independent of mitosis and demonstrate proof-of-concept of our platform for the treatment
of X-linked severe combined immunodeficiency (X-SCID), a rare monogenic disorder caused by mutations in the
IL2RG gene. X-SCID affects 1 in 58,000 births and is rapidly fatal if untreated; current treatments like HSCT offer
only a 70% success rate for long-term immune reconstitution, and even then, significant complications can arise.
Despite advances in clinical methodologies, effective, safe treatments are still lacking for X-SCID and many other
diseases with genetic origins. In Phase I, we will (1) identify and validate DNA targeting sequence motifs for
incorporation to cssDNA that will enable efficient nuclear targeting, and (2) demonstrate and optimize nuclear
delivery of custom cssDNA payloads into established human cell lines. In Phase II we will turn our focus to X-
SCID and (1) validate nuclear delivery of cssDNA-LNPs into clinically relevant CD34+ hematopoietic stem and
progenitor cells (HSPCs), and (2) successfully insert full-length IL2RG gene using a genomic nuclease system
and confirm on-target integration. Lastly (3), we will demonstrate the safety and efficacy of this therapeutic
approach in an in vivo murine X-SCID model. A successful outcome of this project will lead to the establishment
of a proof-of-concept for our gene editing platform both in vitro and in vivo, and lay the foundation for an improved
gene therapy for X-SCID, as well as additional monogenic diseases.

Public health relevance
PROJECT NARRATIVE X-SCID affects approximately 1 in 50,000 to 100,000 live births, leaving these infants without a functional immune system and highly vulnerable to infections. Current treatments like HSCT offer only a 70% success rate for long- term immune reconstitution, and even then, significant complications can arise. It is but only one example of a monogenetic rare disease that could be treated by safe gene function replacement through long DNA insertions. The urgent need for innovative gene therapies is clear, especially as traditional viral vectors pose risks such as insertional mutagenesis, with up to 30% of cases showing serious adverse effects. In response, Kano Therapeutics is developing an innovative platform for full-length non-viral gene insertions leveraging lipid nanoparticles and custom circular single strand DNA payloads offering a safer, more precise solution that minimizes these risks. Initially applied as an improved treatment for X-SCID, the approach is designed to meet the growing demand for effective, scalable gene therapies, addressing the critical gaps in current treatments and aligning with the FDA’s evolving focus on rare diseases. By advancing this technology, we aim to provide a transformative, reliable option for X-SCID patients.